RNA-dependent chromatin targeting of TET2 for endogenous retrovirus control in pluripotent stem cells

PROJECT SUMMARY
Ten-eleven translocation (TET) proteins play key roles in regulating the methylation status of DNA through
oxidizing methylcytosines (5mC), generating 5-hydroxymethylcytosines (5hmC) that can both serve as stable
epigenetic marks and participate in active demethylation. Unlike the other TET-family members, TET2 does not
contain a DNA-binding domain, and it remains unclear how it is recruited to chromatin. Here we show that
TET2 is recruited by the RNA-binding protein Paraspeckle component 1 (PSPC1) through transcriptionally
active loci, including endogenous retroviruses (ERVs) whose long terminal repeats (LTRs) have been co-opted
by mammalian genomes as stage- and tissue-specific transcriptional regulatory modules. We find that PSPC1
and TET2 contribute to ERV and ERV-associated gene regulation by both transcriptional repression via
histone deacetylases and post-transcriptional destabilization of ERV RNAs through 5hmC modification. Our
findings provide evidence for a functional role of transcriptionally active ERVs as specific docking sites for RNA
epigenetic modulation and gene regulation. The goal of this project is to study whether and how TET2 may be
targeted to chromatin via RNAs and RNA-binding proteins leading to RNA hydroxymethylation-mediated
regulation of MERVL and their associated 2C genes for pluripotency of ESCs, as opposed to the sporadic
totipotent 2C populations in ESCs. We hypothesize that RNA-dependent chromatin targeting of TET2 is critical
for direct RNA demethylation and degradation of MERVL transcripts, which may lead to development of
efficient tools in manipulating stem cell and developmental potency. The following three aims will test this
hypothesis and explore stem cell potency control by an intimate interplay among TETs, RBPs, and ERVs. 1)
Establish RBP-dependent functions of TET2 in RNA modification; 2) Explore novel TET2 functions in RNA-
dependent chromatin targeting by regulating RNA targets for pluripotency of ESCs; and 3) Manipulate stem
cell and developmental potency with RNA targeting CRISPR/RCas9 for targeted MERVL RNA modification in
ESCs and developing embryos. The first aim will establish novel functions of TET2 in hm5C modification of
MERVL transcripts in a PSPC1-dependent manner. The second aim will dissect the consequence of hm5C
modification of MERVL transcripts and the molecular mechanism underlying hm5C-mediated MERVL
degradation. The third aim will explore manipulating stem cell and development potency by direct MERVL RNA
modification. Taken together, these three aims will provide considerable novel insight into RNA-dependent
chromatin targeting of TET2 for the posttranscriptional mechanism of MERVL control in stem cell potency. The
project is highly significant as it is expected to establish a new paradigm in understanding ERV regulation, TET
functions in RNA modification, and totipotency.

Public health relevance
RELEVANCE TET proteins play important roles in epigenetic regulation of gene expression including endogenous retroviruses (ERVs), which play critical roles in development, pluripotency, and cancer. Understanding the posttranscriptional control of ERVs via novel TET-mediated RNA hydroxymethylation is expect to result in novel strategies for manipulating cell fates in stem cells and cancer. The proposed research is thus relevant to public health and the part of NIH's mission in developing fundamental knowledge that will help to enhance health and reduce the burdens of human diseases.